ENDOTHELIAL ALPHA V INTEGRIN COMPLEXES MODULATED ACTIN CYTOSKELETAL ORGANIZATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Integrins are cell surface receptors that serve a number of basic cellular functions. One of these functions, which is relevant to the organ edema that occurs in inflammatory diseases like acute lung injury, is the regulation of passage of fluid and solute across the endothelium, the layer of cells lining blood vessels throughout the circulatory system. The Sheppard lab has recently demonstrated that alpha-v integrins modulate endothelial permeability by organizing the actin cytoskeleton. Specifically, alpha-v beta-3 integrin is necessary for rearrangement of actin into cortical distribution that increases vascular barrier strength in response to sphingosine 1-phosphate, a plasma borne barrier-enhancing molecule;on the other hand, alpha-v beta-5 is required for organization of the cytoskeleton into stress fibers that decrease barrier strength in response to thrombin, a blood borne mediator of increased blood vessel leakiness. Our objective is to identify the constituents of the protein complexes associated with these integrins. An ideal approach in this regard is to employ mass spectrometry, where biochemically isolated integrin complexes can be submitted to mass spectrometric sequencing for protein discovery. With this unbiased approach, the distinct actin binding and/or modulatory proteins associated with these two integrins may be identified and studied further to understand how they modulate actin organization. Armed with this powerful information, we may further dissect pathways mediating the opposing biological response of these two integrins and target specific points along their respective pathways as potential treatments for organ edema in the setting of sepsis and other acute inflammatory diseases.